DEVELOP AND EVALUATE ARTIFICIAL SENSORY TRANSDUCERS

Develop and evaluate artifical sensory transducers. These should be suitable for use with functional neuromuscular stimulation (FNS) activated paralyzed hands, which lack normal sensation, during lateral and palmar prehension grasp.